Mechanisms involved in HIV-1 Tat mediated neuronal damage

Presently, more than 40 millions people are infected with HIV-1, and AIDS is the fourth leading cause of death worldwide. The introduction of highly active antiretroviral therapy (HAART) has greatly reduced HIVmediated immunosuppression and mortality. However, it may not prevent neuronal damage associated with HIV-1 infection, and progressive damage to the Central Nervous System may be an emerging problem as AIDS patients live longer. Among the factors that have been shown to promote neuronal toxicity, the viral regulatory protein Tat has captured special attention. Tat protein is secreted by HIV-1 infected host cells and has been shown to enter bystander non-infected cells, including neurons. Recently, we have identified a new mechanism by which Tat can induce neuronal damage. It involves the binding of Tat to tubulin, recruitment of the ubiquitin-proteasome system to the proximity of microtubules, and degradation of microtubuleassociated protein 2 (MAP2), a critical component of the cytoskeleton. Immunohistochemical analysis of clinical samples from HIV-1 encephalopathy (HIVE) brain tissues demonstrated a predominantly cytoplasmic presence of Tat in neurons near microglial nodules, and loss of MAP2 in 70% of the affected neuronal cells. The observation that Tat can deregulate cytoskeletal factors led us to hypothesize that molecular events that depend on cytoskeletal integrity such as RNA trafficking could be also impaired. Our preliminary data confirm the ability of Tat to alter the expression of a subset of small RNAs, called microRNAs, which are known translational repressers. On the basis of these results, we will test the hypothesis that in neurons Tat can alter protein synthesis by modulating the activity of the cytoskeleton, the proteasome and the expression of microRNAs translational repressers. We expect that results from this study will critically redefine our knowledge of Tat-mediated neurotoxicity, and can provide potential targets for more effective therapeutic intervention.